Mapping the neural circuitry underlying walking

Project Summary
Walking is an essential and conserved behavior across the animal kingdom. The ability to move in a
coordinated, robust yet flexible manner is a crucial for an animal’s survival in the ever changing environment.
Motor behaviors are controlled by sensory neuropils in the brain which talk to motor centers such as the ventral
nerve cord (VNC) in the thorax to execute precise motor outputs. Descending neurons are the primary conduits
of information that accomplish this connection between the brain and the VNC. However the downstream
target neurons and complex circuits that precisely govern the execution of a specific kind of limbed motor
output such as running, turning, slowing down, switching gait, climbing, stepping etc remain individually
undefined. This project aims to map these individual circuits that control different walking kinematics. In aim 1,
we will map the post-synaptic targets of descending neurons using a translabeling technique called Trans
Tango. We already know from previous studies that have characterized the morphology of all the descending
neurons in Drosophila, which DNs target the leg neuropils in the ventral nerve chord. These descending
neurons are very likely to be directly implicated in controlling walking behavior. Additionally, we also have
broad behavioral information for a subset of the DNs. Using this existing morphological and behavioral data,
we can start to map out the motor and premotor circuits that are downstream of these DNs and reveal the
distinct circuit components that control specific walking kinematics. Some of the DNs we plan to screen, affect
similar behaviors hence it will be interesting to reveal whether they converge onto similar or different targets. In
the second aim, we aim to use a computational approach search for generation Gal4 lines whose neuronal
expression patterns match the downstream target neurons we want to study. Existing split Gal4 lines will be
identified or new ones will be generated in order to gain genetic access to the downstream circuit neurons of
interest. In the third aim, we will use three behavior setups: Flywalker, the Arena and the fly-on-ball setup to
study a range of walking parameters in high resolution using optogenetics intersectional strategies. We will use
optogenetic activation, silencing and also epistasis experiments to map out which components of the circuit are
sufficient or necessary for a particular walking kinematic.

Public health relevance
Project Narrative An animal’s ability to walk in a regulated manner is controlled by the brain through coordinated neural circuitry. Descending neurons are the bridges connecting the brain to the motor centers in thorax that then controls limbed coordination and movement but the exact circuitry downstream of descending neurons responsible for walking remain undefined. This project aims to map these downstream functional circuit components using neuronal translabeling approaches and assess their contribution to precise, robust and flexible motor behavior in Drosophila.